Vet-LIRN program cooperative agreement

Project Summary
The purpose of the proposed cooperative agreement is to affirm the willingness of this
laboratory to analyze FDA Vet-LRN samples from a variety of different sources, provide
analytical data for potential regulatory use and participate in small scale method
development. This cooperative agreement will bolster the laboratory’s ability of develop
additional assays aimed at detection of toxins and pathogens in animal tissues and feed
and enable increased sample throughput capabilities. This cooperative agreement is
intended to
1) Strengthening coordination of veterinary diagnostic laboratory efforts as related to the
national food safety system
2) Support training, quality assurance processes, proficiency evaluations, data shearing
to support national capacity/capability development.
3) Support harmonizing analytical methods and equipment platforms.
4) Support laboratory efforts to obtain accreditation or adopt a quality system
comparable to international standards.
5) Provide testing results during case investigations of potential animal food or drug
adulteration or contamination.

Public health relevance
Project Narrative The activities outlined in this agreement serve to better safeguard the human and animal food supply systems by enhancing the abilities of the member laboratory to provide analysis of Vet-LRN samples in a timely and efficient manner.